Understanding Impact of Controlled 3D Topographical Design on Biological Interactions

PROJECT ABSTRACT
The interaction of cells with micro- and nano-scale topography is a critical signaling modality in controlling cell
activity. This interaction is ubiquitous in the extracellular matrix where natural multiscale topographic structures
provide mechanotransductive cues, essential for processes like cell migration and polarization. Advances in
nanoengineering have led to the creation of synthetic nanoscale systems that mimic the structure and scale of the
native topography, significantly enhancing our understanding of biological processes at the nanoscale. Despite
these advances, there are significant gaps that impede our ability to effectively harness topographical designs
and topography-cell interactions for biological research and applications. One of the key challenges is the limited
understanding of how topographical cues affect the interplay between multiple biological entities at different scales.
Most studies to date have primarily focused on single cell types on static topographies, overlooking the dynamic
interactions between multiple biological entities in 3D space, which better mimic in vivo environments. Clinical
outcomes and biological effects emerge from the collective behavior of multiple entities in 3D and cannot be
captured simply by studying single cell types in 2D settings. Furthermore, current patterning techniques, such as
lithography and nanogratings, are limited to small-sized 2D surfaces, hindering their progression to the (pre)clinical
phase and leaving their in vivo effectiveness uncertain. Addressing these gaps, my research program is
developing multidisciplinary methodologies to mimic, exploit, and quantify the complex and dynamic interacting
processes between controlled topography and multiple biological entities in 3D space and time (i.e., 4D). In my
lab’s first three years, we have made two major advances: (i) We developed an innovative and versatile bottom-up
nanofabrication approach that enables the creation of controlled nano/micro-topographies on various substrates at
large scales. This method features dynamic topography, allowing for reversible shape transformations without
morphological distortion; and (ii) We studied the interactions between controlled nano/micro-topographies and a
variety of single biological entities, including bacteria, tissue cells, macrophages, and exosomes. This proposal
seeks to extend my lab’s capabilities, which can lead to new therapeutic and diagnostic avenues through
fundamentally transformed knowledge of basic cell physiology. My goals for the next 5 years are: (1) Develop
versatile 3D topographic nanopatterning tools that can accurately replicate dynamic 3D topographies found in
natural biological systems; (2) Develop a suite of 3D model systems to study various types of topography-biology
interactions in 3D space and across diverse pathophysiological and biomedical contexts. Importantly, the methods
will be versatile, scalable, and cell/tissue/disease-agnostic, enabling enhanced fundamental understanding of
material-bio interactions while laying the foundation for advances in disease diagnosis, treatment, and prevention.

Public health relevance
PROJECT NARRATIVE Cells can sense and interact with nanoscale surface features, which often leads to changes in their behavior and functions. This project is set to pioneer generalizable methods that mimic dynamic 3D nanoscale topography found in natural biological systems and will study how various biological entities—including cells and noncellular components—respond to controlled topographical cues in 3D settings. The methods we are advancing will be flexible and broadly applicable, enhancing our understanding of a range of biological processes and interactions at the nanoscale interface while laying the foundation for advances in disease diagnosis, treatment, and prevention.